Examining The Role of Corticothalamic Loops in the Prefrontal Cortex in Temporal Lobe Epilepsy

Abstract
Epilepsy affects approximately three million U.S. adults with one-third of patients displaying inadequate
seizure control with drug therapy alone. Temporal lobe epilepsy, where seizures originate in the temporal lobe
and propagate to the thalamus and downstream cortical regions, is the most common type of drug-resistant
epilepsy. Focal onset seizures originating in the amygdala or hippocampus propagate to the mediodorsal nucleus
of the thalamus (MD) and spread to the prefrontal cortex (PFC). The MD is tightly connected with the medial
PFC and its three subregions: Anterior Cingulate cortex, Prelimbic cortex (PrL), and Infralimbic cortex (IL). Each
subregion contains 5 layers. Cortical pyramidal cells in layer 5 of the PrL and IL are highly interconnected with
the MD – they receive direct input from the MD and send reciprocal input back to the MD, forming a loop. In this
proposal, I will use the amygdala-kindling model of temporal lobe epilepsy in rats to characterize (1) how focal
onset seizures affect MD-PFC loop and (2) how inhibition of the MD-PFC loop affects focal onset seizures. Our
preliminary data suggests that this mutually excitatory loop may act as one route for distribution and spread of
seizure activity. Chemogenetic inhibition of MD projections to the PrL as well as inhibition of layer 5/6 cells in the
PrL and IL abolishes amygdala-kindled seizures. To characterize how temporal lobe epilepsy alters the circuitry
of the PFC, I will use ex-vivo whole-cell patch clamp electrophysiology in kindled and sham-kindled rats to
measure changes in intrinsic electrophysiology properties of pyramidal cells. To understand how PFC projections
to the MD are selectively altered, I will use retrograde viral expression in the MD to focus on intrinsic properties
of layer 5 MD-projecting cells. To understand how the MD-PFC loop is altered, I will use optogenetics in these
same animals to measure synaptic properties and excitatory drive of MD projections onto of layer 5 MD-
projecting cells. Since pyramidal cells in both layers 5 and 6 project to the MD, I will use chemogenetics in
amygdala-kindled rats to identify how selectively inhibiting layers 5/6 pyramidal cells affects seizures. To
determine involvement of PFC subregions in amygdala-kindled seizures, I will measure the degree of seizure
suppression from inhibiting layer 5/6 pyramidal cells in either the PrL or IL. To determine involvement of cortical
projections in amygdala-kindled seizures, I will measure the degree of seizure suppression from inhibiting MD-
projecting cells in the PrL and IL. Through the course of these experiments, I will gain training and experience
with slice electrophysiology, in vivo circuit manipulation, epilepsy models, which will prepare me for future bench-
to-bedside research as a physician-scientist. I will comprehensively characterize physiological markers of
epileptogenesis in downstream regions of temporal lobe epilepsy and identify how closed loop circuits between
the thalamus and cortex are involved in temporal epilepsy. These findings will expand our map of epileptogenic
networks and possible therapeutic targets for drug-resistant epilepsy.

Public health relevance
Project Narrative One third of individuals living with epilepsy do not respond to current therapies, underscoring the need to identify novel targets to treat seizures; network-based therapies are a promising direction but require identifying new circuit-based targets. Despite widespread connectivity with other components of seizure generating networks, the role of thalamic-to-prefrontal cortex circuits in development and control of seizures have not been comprehensively studied. Targeting prefrontal cortex offers a novel target for understanding epilepsy-associated changes in brain circuitry, and a novel target for controlling seizures to improve outcomes for people living with epilepsy.